PHYSIOLOGIC STRESS RESPONSE TO ERCP

It is not known if the anesthetic agent used to perform ERCP influences the physiologic stress response to the procedure. Anesthesia itself may influence the development of and/or severity of ERCP-induced pancreatitis based on its demonstrated ability to modify the stress response to surgery. This study compares two anesthetic approaches - benzodiazepine and narcotic, or propofol - for potential differences in stress response mediators, such as cytokines, acute phase reactants, glucocorticoids, and prostaglandins. New protocol.